MAITEC FOR PATIENTS WITH MULTI-DRUG RESISTANT TUBERCULOSIS AND AIDS

The purpose of this trial is to assess the safety of liposome encapsulated gentamycin (Maitec) in the treatment of AIDS patients who have multi-drug resistant tuberculosis in combination with three second-line anti-tuberculosis drugs.